Role of T cells in Uremic Cardiomyopathy

Abstract
The work outlined in this revised proposal for the Mentored Clinical Scientist Research Career Award (K08)
will provide the training and mentorship necessary for the candidate to develop into an independent
investigator and expert in the immunological consequences of CKD, specifically in relation to cardiovascular
comorbidities. Cardiovascular disease is the leading cause of death for the nearly 20 million Americans living
with chronic kidney disease (CKD). Uremic cardiomyopathy, characterized by left ventricular hypertrophy
(LVH) and diastolic dysfunction, predicts mortality among patients with CKD. The underlying mechanisms
contributing to the development of uremic cardiomyopathy are incompletely understood, limiting treatment
options. The literature suggests that the accumulation of pro-inflammatory T cells during CKD confer risk for
cardiovascular disease via unknown mechanisms, leading us to further explore a role for T cells in uremic
cardiomyopathy. We have exciting preliminary data suggesting T cells mechanistically underlie the pathological
cardiac changes in an experimental model of CKD. Our overarching hypothesis is that T cells altered by
uremia contribute to cardiac remodeling during CKD.
The scientific approach in this proposal utilizes a murine model of CKD that results in uremic
cardiomyopathy (LVH and diastolic dysfunction) and accumulation of pro-inflammatory T cells. First, we will
identify the differential role of the two major subsets of T cells (CD4+ and CD8+) in the pathogenesis of uremic
cardiomyopathy. Next, we propose interrogating the role of T cells bearing the co-inhibitory receptors, PD-1 or
KLRG1, in uremic cardiomyopathy via adoptive transfer studies and the necessity of the PD-1 signaling
pathway using antibody blockade in vivo. Finally, we will investigate the contribution of the co-stimulatory
pathway, OX40, including how it relates to the up-regulation of KLRG1 and PD-1 in T cells during CKD. This
work will provide important mechanistic insight into the role of T cells during uremic cardiomyopathy, paving
the way for novel therapeutic strategies in patients with CKD.
We have assembled of a team of NIH-funded mentors with diverse and complementary expertise to support
the candidate’s development in three scientific domains: immunology, cardiovascular biology, and chronic
kidney disease. The career development plan is structured to expand knowledge in immunology, master
advanced experimental methods in immunology, further develop skills in experimental methods in
cardiovascular biology, mature skills in scientific communication, and lay a foundation to enable translation of
basic science discoveries in the future. The candidate’s primary mentor, Dr. Mandy Ford, is a classically-
trained immunologist with expertise in T cell memory development and costimulatory signaling. Dr. Ahsan
Husain, as co-mentor, will provide expertise in cardiovascular biology, and Dr. Larry Greenbaum will assist me
in forming relationships and project ideas for future translational studies.

Public health relevance
Project Narrative Chronic kidney disease (CKD) causes early death from a type of heart failure due to a thick and stiff heart. Our project is trying to better understand what causes the thick and stiff heart during CKD to find new ways of treating and preventing death from this type of heart failure. Our research focuses on how a particular type of immune cell, called the T cell, is affecting the health of the heart during CKD.